Mechanical Regulation of Adipose TissueFibrosis and Metabolic Disease

PROJECT SUMMARY/ABSTRACT
Adipose tissue fibrosis is an irreversible disorder associated with obesity-related conditions, including type 2
diabetes, non-alcoholic fatty liver disease, and cardiovascular disease. Adipocytes within white adipose tissue
(WAT) are surrounded by an extracellular matrix (ECM) whose composition and remodeling are of crucial
importance in modulating mechanotransduction pathways – pathways by which cells sense and respond to their
environment - that control cell fate. During obesity, aberrant WAT expansion can induce physical constraints on
adipocytes, triggering an inflammatory response, disrupting lipolysis, and reducing insulin sensitivity, impairing
WAT's ability to regulate energy balance. To address the complex role of adipose tissue dysfunction in metabolic
disease, this project aims to uncover the early mechanisms driving adipose tissue fibrosis and its influence on
metabolic disease, thus guiding the development of targeted therapies. Previous in vitro studies have
determined that the ECM protein, aortic carboxypeptidase-like protein (ACLP), enhances pro-fibrotic, anti-
adipogenic pathways through transforming growth factor β (TGFβ) receptor signaling. My preliminary data
supports ACLP-dependent activation of integrin-mediated GTPase signaling and cytoskeleton remodeling
potentially through its interactions in the ECM. The collagen-binding discoidin domain of ACLP activates
adipocyte progenitor differentiation and enhances cell spreading independent of TGFβ signaling, suggesting an
domain-dependent role in fibrotic mechanical signaling. However, the specific pathways by which ACLP activates
mechanotransduction in adipose tissue to induce fibrotic remodeling remains unknown. We hypothesize that
obesity-induced ACLP secretion in the ECM of WAT induces a profibrotic, anti-adipogenic phenotype through
integrin-mediated mechanotransduction, contributing to metabolic disease. To investigate these underlying
mechanisms, we will employ a combination of biomechanical techniques, in vitro assays, and in vivo models.
Aim 1 will delineate the pathways by which ACLP regulates mechanotransduction in the ECM, employing
biomechanical measures and in vitro assays to characterize mechanotransduction pathways in mouse stromal
vascular progenitor cells and adipose explants. Aim 2 will investigate the role of ACLP in diet-induced obesity,
adipose tissue fibrosis, and metabolic disease in vivo using an ACLP loss-of-function mouse model, combined
with single-cell RNA sequencing to identify progenitor population changes caused by ACLP loss-of-function.
These studies will provide a comprehensive evaluation of the mechanotransduction pathways regulated by
ACLP, highlighting potential targets for future therapeutics in combating adipose tissue fibrosis and metabolic
disease. Moreover, my proposed plan will provide diverse training in cellular biology, bioinformatics, and
biomedical engineering, equipping me with the skills necessary for success as an independent research scientist.

Public health relevance
PROJECT NARRATIVE Adipose tissue fibrosis is an underlying factor in metabolic disease, yet a critical knowledge gap persists regarding the mechanisms in which initiate and progress the disease. We aim to investigate the role of aortic carboxypeptidase-like protein, an extracellular matrix protein, in promoting a pro-fibrotic, anti-adipogenic phenotype via mechanotransduction pathways and its association with metabolic disease. The insights gained from this study will provide a deeper understanding of the mechanotransduction pathways underlying fibrosis and unveil potential therapeutic targets for obesity-related metabolic diseases.